Integrated Genomics of Mucosal Infections

Overall Project Summary
This application requests funding for a Genomics Center for Infectious Disease (GCID) in the Texas Medical
Center (TMC) that comprises a multidisciplinary, integrated team of basic and physician scientists at Baylor
College of Medicine, the University of Texas-Houston School of Public Health, and MD Anderson Cancer Center.
The overall goal of our GCID is to: i) leverage our decades of experience in genomic sequencing
technology with our renowned clinical expertise, and the use of novel ex vivo organotypic models of
human intestinal and pulmonary function, to create a platform for large scale genomics-based
interrogation of host-mucosal pathogen interactions in the context of human tissues, and ii) utilize this
platform for the discovery of novel therapeutic and diagnostic targets based on host and microbial
genomic and transcriptomic profiles. Project 1 (PL: A. Maresso, PhD) will dissect the genomic elements that
confer the ability of pathogenic members of the Enterobacteriaceae and Enterococcaceae to associate with the
human intestinal mucosa while also determining the host response to this association. Project 2 (PL: M. Estes,
PhD) will leverage integrated analyses of human norovirus and respiratory syncytial virus full-length genomic
sequences and characterization of the ecological niche of samples from clinically relevant patient sub-groups for
new understanding of viral replication, recombination and evolution, induction of disease and host factors
required for susceptibility to infection and pathogenesis. Project 3 (PL: D. Corry, MD) will test the hypothesis that
fungal diversity, virulence, and individual innate immune responses to fungal burdens underlie persistent,
treatment-resistant moderate to severe asthma in a new paradigm whereby fungal burden within the respiratory
tract (“airway mycosis”) may have a causative role in development and persistence of allergic lung inflammation.
Project 4 (PL: P. Okhuysen, MD) will build on a novel Cryptosporidium discovery made by the project leaders
and test the hypothesis that one or more indole-producing commensal microbes in the gut can prevent or
eliminate Cryptosporidium infection. All four research projects will utilize human intestinal and lung organoid
cultures along with niche-specific, defined microbial communities supplied by the Organoid and Minibioreactor
Array Cultivation Core and a large collection of unique clinical samples and isolates, incorporating cutting edge,
high-throughput sequencing strategies and technologies supplied by the Sequencing Technology (ST) Core.
Paradigm-shifting discoveries, data, tools, and reagents will be disseminated to the infectious disease community
by the Data Management Analysis and Resource Dissemination (DMARD) Core through a state of the art portal
developed by DNAnexus. The result will be a comprehensive genetic profiling of hosts and microbes in human
infection models that will reveal pathogen genetic variants, and individual host response phenotypes to inform
precision medicine-based therapeutics and diagnostics, both for the pathogens in this proposal and a broad
spectrum of mucosal infectious diseases that severely impact human health.

Public health relevance
New diagnostics and drugs to protect us from infectious diseases with the greatest health impact requires a thorough understanding of the infection process from the perspective of the pathogen, the host, and the ecological niche in which host-pathogen interaction occurs. Using new capabilities in genomic sequencing, unique clinically relevant samples from infected and uninfected individuals, and new model systems that allow us to study human infection, we will investigate disease mechanisms for several important bacterial, viral and fungal and parasite pathogens and discover new targets for diagnostics and drug development.